CHANGES IN AMINOPYRINE METABOLISM IN PATIENTS NEW TO HOUSTON AREA

The purpose of this study is to measure liver functions by the aminopyrine breath test in newly-arrived Medical Center personnel to determine if the changes we have seen are associated with long- term residence in the Houston area. Control studies of similar individuals arriving at the University of Nebraska will also be carried out.